Outreach and Dessimination

COMPONENT SUMMARY (See instructions): The outreach and dissemination unit will use a variety of strategies to acquaint the larger Northwestern community, e.g., alumni, and students, fellows, and faculty at other institutions, with the mission and activities of the Network as a whole and with Northwestern's PS-OC in particular. The unit will also encourage and support collaborations between the NU PS-OC and outside investigators. These strategies include: [unreadable] PS-OC website [unreadable] Webcasts, podcasts [unreadable] Annual symposium and related mini-symposia [unreadable] Center brochure [unreadable] Placement of articles about the PS-OC in NU print and electronic publications [unreadable] Summer research experience for underserved college students [unreadable] Support for collaborations with investigators outside of the Network